Pathological striatopallidal neuronalensembles in learned motor impairment in PD

ABSTRACT
In Parkinson's disease (PD), degeneration of dopaminergic (DA) neurons leads to profound motor impairment.
Although motor symptom is initially treatable by the DA precursor levodopa (L-DOPA), patients experience dis-
abling motor fluctuations, including a shortened duration of action for L-DOPA, only partially treated with
pharmacological means and deep brain stimulation. Preventing L-DOPA's declining effectiveness will greatly
improve patients' quality of life and reduce social cost. Emergence of disabling motor fluctuation is associated
with the decline of a component of L-DOPA's antiparkinsonian response, known as the long duration response
(LDR). The LDR is a long-lasting motor improvement that persists long after L-DOPA plasma level has re-
turned to baseline, gradually decaying over many hours to days after discontinuation of L-DOPA. Motor
fluctuation may be caused by LDR declining too rapidly, and treatments that halt LDR decay may prevent mo-
tor fluctuations. However, the mechanism underlying LDR is currently unknown. Using two distinct motor tasks,
we recently found that both induction and decay of LDR is task-specific, requiring the pairing of task exposure
with L-DOPA (for LDR induction) or with L-DOPA withdrawal (for LDR decay). These results point to associa-
tive learning and neuroplasticity as the underlying mechanism. Furthermore, indirect pathway medium spiny
neurons (iMSNs) are activated by LDR decay, and D2 receptor (D2R) knockout greatly slowed LDR decay.
Based on the above results and previous findings that i) iMSN activation suppresses movement and may nor-
mally function to inhibit competing responses; ii) iMSNs undergo aberrant long-term potentiation (LTP) when
DA depleted, we will test the hypothesis that gradual motor impairment during LDR decay results from aberrant
LTP in specific ensembles of iMSNs that are normally suppressed during normal movement by D2R stimula-
tion, but become pathologically active during task exposure if DA is depleted. Using Drd2-EGFP mice to label
iMSNs, we will first examine whether L-DOPA-rescued motor performance vs. LDR decay activate different
iMSN ensembles in the same mouse: we will tag task-activated iMSN ensemble at the 1st time point using a
Fos-promoter driven, doxycycline-gated fluorophore, then tag task-activated iMSN ensemble at the 2nd time
point using endogenous Fos labeling, and compare their co-localization. We will then examine whether this
“incorrect” iMSN ensemble activated during LDR decay (visualized by a Fos-driven fluorophore) has synaptic
input changes that are consistent with the occurrence of LTP. Finally, we will use Fos-driven opsins to bi-
directionally modulate this “incorrect” iMSN ensemble to show its causal, pathological role: that its activation
leads to task-specific motor impairment, and its inhibition recues impairment task-specifically. By demonstrat-
ing the existence of, and the role of, pathological iMSN ensembles in task-specific motor impairment in PD,
and by identifying the form of aberrant neuroplasticity that leads to their recruitment during movement, these
experiments will form a basis for future studies to develop novel treatments to halt or reverse LDR decay and
motor fluctuation.

Public health relevance
NARRATIVE The effectiveness of the widely-prescribed drug, levodopa, in treating motor impairment in Parkinson's disease declines over time, in part due to a progressive shortening in the time for which each dose of levodopa is effec- tive. During early Parkinson's disease, each dose of levodopa has a long-lasting therapeutic effect that decays gradually upon levodopa discontinuation; we found that this progressive decay is only seen with continued per- formance of the same task, and that it activates the “no-go” pathway of the basal ganglia – a brain region important for movement, whose function is severely impaired in Parkinson's disease. Using a novel technique to visualize and manipulate subpopulations of neurons that are activated by specific motor tasks, we will exam- ine whether the decay of levodopa's long-lasting therapeutic effect is caused by the pathological activation of an “incorrect” subpopulation of “no-go” pathway neurons, the confirmation of which may lead to development of novel effective treatments that reverse motor impairment.